Core F - Neuroimaging Core

PROJECT SUMMARY – IMAGING CORE (F)
The UCSF ADRC Neuroimaging Core (Imaging Core) is a critical component of the center’s efforts to advance
early and accurate diagnosis of neurodegenerative disease. Through the use of MRI- and PET-based imaging,
we have helped to define the imaging abnormalities that characterize atypical and early age of onset
neurodegenerative disorders, in particular FTD and early-onset AD, and to establish the central role for imaging
in diagnosis of rapidly progressive dementias (RPDs). We have pioneered the use of new MRI techniques, and
new PET ligands, in FTD and AD as they have emerged, and done extensive work correlating these techniques
with other biomarkers, genetics, and neuropathology. Imaging is also a critical component of programs at our
center that combine measures of functional, anatomical, and molecular change with neuroscience-based
assessments to understand changes in language, social-emotional function, visuospatial, executive function,
and other impairments caused by neurodegenerative disease. We have been enthusiastic contributors to
national efforts, including the Standardized Centralized Alzheimer’s and Related Neuroimaging (SCAN) project,
and led national and international efforts to characterize atypical neurodegenerative diseases, including FTD,
atypical and early onset AD, while developing new collaborations to study traumatic encephalopathy syndrome
(TES). For the upcoming cycle, the Imaging Core will continue to support our ADRC by coordinating acquisition,
archiving, and processing of 3T structural and functional MRI, and amyloid, tau, and FDG PET images, making
these images accessible to local and national ADRC investigators, and providing imaging based amyloid, tau
and neurodegeneration (AT(N)) staging data for select clinical populations. We will purse the following aims:
Aim 1: Collection, archiving, and quality control (QC) of MRI and PET images in ADRC participants,
including: MP-RAGE, FLAIR, T2-weighted, diffusion, ASL perfusion, ICN-fMRI, and amyloid, tau and FDG PET
scans. We will upload MRI and PET imaging datasets to the SCAN project. Aim 2: Development and
implementation of standard and innovative analytic tools to characterize disease related changes in brain
volume, white matter microstructure, white matter signal hyperintensity, ICN-fMRI-based connectivity, cerebral
perfusion, and PET ligand binding. Aim 3: Provide AT(N) staging information for ADRC participants who
undergo amyloid and tau PET to the Clinical Core for participant feedback, and to the Data Management
and Statistics Core for analysis. We will use funds allocated for MRI and PET to focus on AT(N) characterization
of Chinese and Latino American participants recruited via the Outreach Recruitment and Engagement Core,
and patients with atypical clinical presentations of AD. Aim 4: Support research training by working with the
Research Education Component (REC) to teach principles of image acquisition and analysis, and clinical
interpretation of amyloid and tau PET scans, and support trainees who wish to incorporate image analysis into
their research.